EXAGGERATED PLATELET REACTIVITY IN MAJOR DEPRESSION

This study is an ammendment to SPID 3250. It will evaluate alterations in platelet reactivity and sympathetic tone in patients with major depression, and then re-evaluate these patients after 6 weeks of treatment with the anti-depressant, paroxetine. Data were analyzed, and results submitted for publication.